“Does getting older signal improved mood repair for people with early-onset mood disorder histories? A longitudinal study of outcomes and mechanisms across middle age.”

Abstract This application responds to RFA-MH-17-405 Adult Maturational Changes and Dysfunctions in Emotion Regulation. As the RFA notes, aging is associated (for most people) with increasing emotional well-being, emotional stability, and a positivity bias. While these maturational changes are believed to reflect improved emotion regulation skills (like better ways of attenuating sad mood), the literature on emotion regulation strategies and age is decidedly equivocal. Further, little is known about when maturational changes may occur given the scarcity of longitudinal studies and the use of designs, which contrast highly divergent age groups. And it is not known how psychopathology affects presumed adult maturational changes in affect-related skills. We propose to build on a unique sample of Ss, heterogeneous with respect to risk of depressive disorder, who (in prior research studies) repeatedly reported during ages 18-35+ on their emotional well-being and how they attenuate sadness/distress (mood repair); their autonomic nervous system (ANS) functioning associated with affect processing was also assessed via peripheral measures. We propose to re-assess n=225 with histories of diagnosed depression and n=200 with no histories of depression once more, and thus extend the data base up to age 59 years, covering middle-age. We will identify latent trajectories of trait mood repair from ages 18 to 59 years and determine its correlates and the effects of personality, treatment exposure and ANS physiologic functioning on class membership. We also will examine the ability to repair mood in the laboratory via two adaptive cognitive regulation strategies: attention-refocusing and neutral reappraisal. Finally, we will use a novel experimental procedure (the Cognitive Effort Discounting Paradigm or COG-ED), which quantifies the subjective cost of cognitive effort (involved in cost-benefit computations to perform a task), to examine the impact of affective load on effort-based decision making. We will test several clearly articulated hypotheses about : i) the effects of depressive illness history and sex on positive maturational effects in mood repair with age, ii) the predictive/moderating values of personality and treatment exposure on age-related mood repair changes, iii) the relations of latent-class mood repair trajectories to sex and shifts in ANS functioning over time; iv) the predictive value of latent-class mood repair trajectories for mood repair success in the laboratory; v) ever-depressed and never-depressed group-related differences on the COG-ED, and vi) the relations of COG- ED performance to mood repair trajectory membership and lab-based mood repair performance via attention refocusing. Our study will fill several gaps in the literature on emotion regulation and aging. It also represents the first step to assess the extent to which a neuro-economic approach to decision making reflects a mechanism that may explain mood repair choices. Findings on mood repair trajectories and COG-ED outcomes have public health implications in the areas of depression prevention and treatment.

Public health relevance
PROJECT NARRATIVE This study will characterize longitudinally the mood repair trajectories of adults with histories of depressive disorders and healthy controls, aged 18 to 59 years; examine how such trajectories relate to contextual factors, mood repair performance in the lab, and physiological functioning; and investigate a potential cognitive mechanism related to mood repair responding. The results may inform mental health interventions across the adult age span.